Immune suppressor mechanisms in patients with GI cancer

We performed correlative studies using samples from patients enrolled in our trials. This includes patients with HCC and CCC treated with immune checkpoint inhibitors +/- anti-VEGF, patients with CRC treated with immune checkpoint inhibitors plus oncolytic virus and patients with liver tumors treated with vancomycin. Some of the studies have been concluded and have been published (CRC: PexaVec) other have been submitted and should appear in the near future (CCC plus immune checkpoint inhibitors), Vancomycin treatment of patients with liver dominant diease